Administrative Supplement: The Midwest Center for Cryo-Electron Tomography

PROJECT SUMMARY/ABSTRACT
Not applicable to the application.

Public health relevance
PROJECT NARRATIVE Not applicable to the application.